PROTACs Regulating HIF in Mucosal Inflammation

Project Summary
Inflammatory bowel disease (IBD) represents a group of chronic mucosal inflammatory disorders, including
Crohn's disease and ulcerative colitis. Many IBD patients have limited therapeutic options. Oxygen metabolism
and hypoxia play prominent roles in healthy intestinal tissue and energetic shifts during active inflammation.
Hypoxia triggers the temporal stabilization of the transcription factors hypoxia-inducible factors HIF1 and
HIF2, which are essential in maintaining intestinal homeostasis. HIF-1/2 are regulated by a family of prolyl
hydroxylases (PHDs). Inhibition of PHDs results in transient stabilization of HIF-1/2 and thus, PHD inhibitors
(PHDi) have become attractive targets for the therapeutic treatment of IBD. We have investigated the chemical
knockdown of PHDs by “hijacking the proteasome system” using proteolysis targeting chimeras (PROTACs),
heterobifunctional compounds that degrade proteins of interest. PROTACs advantages include enhanced
specificity, higher potency, and sustained inhibition. In ongoing studies, we have produced a panel of PHD
targeting PROTACs. In vitro, we observe significant PHD2 degradation and modest HIF stabilization at
nanomolar concentrations, a 2-3 log increase in potency compared to PHDi. Importantly, the wound healing
capacity of epithelial cells is significantly enhanced. These results warrant further investigation as there is vast
room for improvement in developing fine-tuned PROTACs. The intent of this proposal is to design HIF stabilizing
PROTACs and elucidate their role in barrier formation and wound healing as supported by metabolic shifts. The
end goal is to reveal the therapeutic potential of PROTAC-HIF stabilization in murine models of IBD.
The applicant, Dr. Ornelas Sanchez, has established a scientific niche in which to build a foundation for
independent research on the development of PROTACs that influence inflammatory pathways. Dr. Ornelas
Sanchez and his mentor, Dr. Colgan, assembled a mentorship committee to regularly meet as a group to provide
feedback, critique the research plans, monitor publications, and provide career advice. Of note, he will train
under the supervision of Dr. Reigan to learn molecular modeling of PROTACs. Furthermore, we have identified
coursework to expand his knowledge in computational modeling, fundamental molecular biology, and cellular
biology. Dr. Ornelas Sanchez will submit his work to present at conferences specific to his research to share his
results, network with colleagues and potential collaborators, and get valuable feedback. His development will
benefit from continued participation in the Mucosal Inflammation Program (MIP), a multi-disciplinary, multi-
departmental program initiated to study mechanisms of mucosal inflammation and resolution. The MIP fosters a
unique environment for collaboration between physician and research scientists and establishes an environment
for young investigators to flourish and develop. The facilities and resources available to and development plan
built for Dr. Ornelas provide an ideal environment and path towards his successful transition to independence.

Public health relevance
Project Narrative The loss of intestinal barrier function is a hallmark of inflammatory bowel disease (IBD), a condition afflicting millions worldwide and with limited therapeutic options. The transcription factor hypoxia inducible factor (HIF) has been identified to have prominent roles in intestinal barrier maintenance, restoration and wound healing leading to potential therapeutic properties, in turn HIF is regulated by a family of enzymes termed PHDs. This work will explore the design and synthesis of PROTACs that regulate HIF pathways through the degradation of PHDs and assess their impact in barrier restoration, wound healing, metabolic shifts and ultimately their therapeutic potential in murine models of inflammatory disease.